ISOLATION AND CLONING OF HUMAN DNA REPAIR GENES

An assay has been developed in which the DNA repair deficiency of the human genetic disease Xeroderma Pigmentosum is transiently complemented by the introduction by microinjection of cytoplasmic poly(A)+RNA derived from Hela cells. This assay will be utilized to isolate a cDNA copy of repair mRNAs by zoom cloning techniques. The cDNA copy will be used as a probe to identify a clone containing the genomic copy of the repair gene from a human, recombinant DNA library. Structural analyses of the cloned genes and biochemical characterization of their expression products will be performed. These studies should help to elucidate the molecular mechanisms of human, DNA excision repair and the pathobiology of XP.